Clinical and genetic risk factors associated with adverse long-term health outcomes after curative therapies in individuals with sickle cell disease

Summary
Our primary objective is initiating a personalized approach to curative therapies in children and adults with sickle
cell disease (SCD) to maximize benefits and limit adverse outcomes. Limited systematic efforts exist to elucidate
long-term health outcomes following curative therapies for SCD. The paradigm of focusing only on the initial cure
is analogous to what occurred in pediatric oncology in the 1980s with successful curative therapies.
Subsequently, curative therapies were associated with increased risk for organ dysfunction and malignancies,
leading to a new field, survivorship in pediatric oncology. With emerging curative therapies for SCD (allogeneic
[allo] hematopoietic stem cell transplant [HSCT], gene therapy/editing), long-term health outcomes studies are
time-sensitive and critical to inform personalized choices. Unfortunately, adverse outcomes have started to
emerge after SCD curative therapy. Specifically, 10% of the deaths following HSCT occur more than 5 years
after HSCT. Further, our group has demonstrated therapy-related myeloid neoplasms and clonal hematopoiesis
of indeterminate potential (CHIP) may occur when graft rejection/mixed chimerism is present (seen in 5 of 76
patients with SCD after HSCT). Thus, risks of cure in SCD must be measured against the benefits of cure,
including stabilization of lung function (FEV1) and improved tricuspid regurgitant jet velocity [TRJV]. Ultimately,
the shortened lifespan of individuals with SCD, attributable to declining heart (elevated TRJV), lung (decreased
FEV1), and kidney (decreased eGFR) function, for which curative therapies were designed to ameliorate, must
be measured against favorable and unfavorable late outcomes. In our multicenter retrospective-prospective
cohort, we will test the following hypotheses: 1a): myeloablative curative therapies for children with SCD will
result in progressive pulmonary and renal dysfunction when compared to children with SCD receiving standard
therapy; 1b): nonmyeloablative HSCT for adults with SCD will result in no significant change in FEV1% predicted,
but will lead to accelerated decline in eGFR when compared to adults receiving standard therapy; 2)
nonmyeloablative HSCT for adults with SCD will be associated with a clinically significant improvement in TRJV
following HSCT; and 3) in adults with SCD, proliferative and genotoxic stress uniformly related to
nonmyeloablative allo-HSCT and myeloablative gene editing will lead to post-HSCT therapy-related myeloid
neoplasm of recipient origin. We will address these hypotheses with the following aims: 1) evaluate the incidence
of pulmonary and renal function in 1a: children with SCD receiving myeloablative curative therapies; and 1b:
adults with SCD receiving nonmyeloablative allo-HSCT, compared to a pre-existing cohort of children and adults
with SCD; 2) determine whether there is a clinically significant improvement in TRJV in adults with SCD, at least
half having TRJV > 2.5 m/s, following nonmyeloablative allo-HSCT, and 3) evaluate the prevalence, incidence
and evolution of CHIP following non-myeloablative HSCT or myeloablative gene editing in adults with SCD.

Public health relevance
NARRATIVE Our primary goal is to delineate adverse long-term health outcomes after curative therapies in children and adults with sickle cell disease (SCD). Despite the recent success of curing sickle cell disease, there have been limited systematic efforts to elucidate long-term health outcomes. Ultimately, the shortened lifespan of young adults with SCD, attributable to declining heart, lung, and kidney function, for which curative therapies were designed to address, must be measured against favorable and unfavorable late outcomes (mortality and morbidity) of these therapies.